Nicotinamide nucleotide transhydrogenase regulates redox balance in atherosclerosis

PROJECT ABSTRACT
Atherosclerosis, a progressive chronic inflammatory disease of the vessel wall, is regulated by oxidant stress
throughout the course of disease development. Endothelial dysfunction is a critical, initiating step in the
development of atherosclerosis and increasing evidence implicates mitochondrial reactive oxygen species
(ROS) as an important contributor to endothelial dysfunction and vascular inflammation. Nicotinamide nucleotide
transhydrogenase (NNT) is emerging as an important enzyme in the regulation of mitochondrial NADPH levels
which can have a significant impact on a number of metabolic pathways through the regulation of mitochondrial
redox balance. Preliminary data from our laboratory supports this concept demonstrating that NNT expression
is reduced in the endothelium of atherosclerotic patients when compared to healthy controls. These data are
consistent with previously published data from our laboratory indicating that AAV8-PCSK9 and high fat diet
treatment led to increased plaque burden in C57Bl/6J mice that lack NNT. Recent studies utilizing small hairpin
RNA knockdown of NNT in human aortic endothelial demonstrates increased hydrogen peroxide production that
is associated with reductions in mitochondrial NADPH and impairment of downstream antioxidant enzymes
glutathione peroxidase and glutathione reductase. Furthermore, the loss of NNT in these cells also led to
increased adhesion molecule expression and inflammatory cell trafficking suggesting that NNT’s role in
regulating mitochondrial balance can play a critical role in modulating atherosclerotic plaque development. We
have confirmed these observations in vivo using a novel endothelial specific knockout mouse where the loss of
NNT promotes enhanced adhesion molecule expression in the aortic arch of mice subjected to AAV8-PCSK9,
partial carotid ligation, and high fat diet in a model of disturbed flow induced plaque development. Building upon
these findings, we propose that the loss of NNT activity contributes to a pro-oxidative mitochondrial
phenotype that exacerbates the progression of atheroscelrosis by enhancing mitochondrial ROS
production, endothelial dysfunction, and vascular inflammation . To test this hypothesis, studies are
proposed that will determine i) if NNT inhibits mitochondrial ROS production and preserves mitochondrial
antioxidant activity and oxidative metabolisim in human vascular endothelial cells; ii) if reduced NNT expression
and increased mitochondrial ROS production stimulates Nox activity that contributes to reduced NO bioavailibilty
and promotes endothelial activation; and iii) if endothelial NNT critically regulates mitochondrial redox balance
and vascular function in mice treated with high fat diet. Data from the proposed studies will identify NNT as a
master regulator of mitochondrial function and ROS production whose absence exacerbates the development of
atherosclerosis by promoting endothelial dysfunction and vascular inflammation, leading to increased plaque
development.

Public health relevance
PROJECT NARRATIVE Atherosclerosis is one of the leading causes of mortality in the United States and reactive oxygen species have been shown to play a critical role in atherosclerotic plaque development. Clinical trials utilizing antioxidant therapies have been unsuccessful and we propose that nicotinamide nucleotide transhydrogenase (NNT) can reduce the development of atherosclerosis by regulating mitochondrial ROS production and preserving normal endothelial cell function. Results from these studies will highlight NNT as a master regulator of mitochondrial antioxidant activity and as a novel therapeutic target in the treatment of atherosclerosis.